Mapping the Neural Organization of Language from Words to Syntax

Summary (Project 4)
Acquired disorders of language, such as aphasia, can have devastating effects on an
individual’s quality of life and livelihood. Up to 2,000,000 people in North America have aphasia
making it a significant public health concern. The goal of Project 4 is to improve our ability to
diagnosis, treat, and predict recovery from aphasia using quantitative and theoretical models of
how language works and how it is implemented in the brain. As part of the Center for the Study
of Aphasia Recovery (C-STAR), this project has three specific aims: (1) to apply our MPT model
to treatment outcome evaluation and recovery prediction, (2) to extend our quantitative and
neural model of word production, and (3) to extend our theoretical scope to include syntax.
Although Project 4 has a bit more theoretical slant that the other three Projects, we have made
a concerted effort to also emphasize the clinical application of the project.

Public health relevance
Project 4 The goal of Project 4 is to improve our ability to diagnose, treat, and predict recovery from aphasia using quantitative and theoretical models of how language works and how it is implemented in the brain. Project 4 is highly collaborative in nature as it relies on data from Projects 1 and 2 and repeats some analyses from Project 3 but with a different analysis approach.